Role of PCIF1 in Regulating Host-HIV interactions

PROJECT SUMMARY
RNA modification is an emerging concept because a diverse set of modified nucleotides are found in mRNA
sequences. The m6A modification is catalyzed by RNA methyltransferase complex containing METTL3 that
catalyzes the addition of a methyl group at N6 position of adenosine which affects gene expression via
regulation of RNA metabolism, function, and localization. N6,2’-O-dimethyladenosine (m6Am) is an abundant
RNA modification located adjacent to the 5’-end of mRNA 7-methylguanosine (m7G) cap structure. Since
m6Am is found at the first transcribed nucleotide in ~30% of the cellular mRNAs, m6Am can have a major
influence on gene expression of the transcriptome. Human Phosphorylated CTD Interacting Factor 1 (PCIF1)
as cap-specific adenosine-N6-MTase (CAPAM), that catalyzes cap-specific m6A methylation on 2’-O-
methylated A at the 5’-ends of mRNAs. So far, the role of m6Am RNA modification and the catalytic function of
PCIF1 in biological and disease processes, especially in regulating viral infections and host-pathogens
interactions have not be determined. Despite remarkable success in treating HIV/AIDS, we do not have a
functional or complete cure for the disease. The molecular networks of host cell regulating HIV-1 transcription,
replication, and latency are not completely understood. The overall objective of this proposal is to delineate the
molecular and cellular mechanisms by which HIV-1 (HIV) infection alters host transcriptional and translational
programs. Our project has three specific aims: Aim 1: Define the dynamics and mapping of human m6Am RNA
methylome by HIV infection and methamphetamine (MA) exposure. Aim 2: Determine how HIV alters m6Am
methylome of host cell. Aim 3: Determine how RNA modifications influences HIV pathogenesis. Successful
completion of these aims will reveal function of PCIF1, and a new regulatory mechanism involved in HIV gene
expression and latency.

Public health relevance
PROJECT NARRATIVE N6,2’-O-dimethyladenosine (m6Am) is an abundant RNA modification located adjacent to the 5’-end of mRNA 7-methylguanosine (m7G) cap structure that can have a major influence on gene expression of the transcriptome regulating immunity and host-virus interactions. This project will define how HIV infections reprogram host epitranscriptomes in the presence and absence of methamphetamine to cause immune dysfunctions. Results of the proposed studies would provide insight into new mechanisms and targets for developing innovative approaches to eradicate or cure HIV infection.